Environmental Changes and Health Outcomes across 25 Years: Four US Cities

ABSTRACT While observational research suggests an association between obesity-related social environment factors with obesity and cardiometabolic risk factors, very little research has addressed the specific factors and pathways linking the social environment to cardiometabolic risk. The primary reasons for this lack of research are: 1) lack of high quality data on diet, activity, measured height and weight over time linked to cardiometabolic risk biomarkers; 2) lack of fine-grain longitudinal data on the introduction, renovation, and closure of food- and activity-related environmental features; and 3) lack of complex statistical models examining each piece of the time-dependent, complex system, accounting for the process by which food, activity, and transportation facilities are established and expanded and the potential for individuals to selectively migrate to locate near such facilities. The 25-year, longitudinal Coronary Artery Risk Development in Young Adults (CARDIA) study provides a wide age range, high quality longitudinal, biological, behavioral and anthropometry and biomarker data of CARDIA, geographic diversity, and different patterns and pace of change across the four baseline cities: Birmingham, Chicago, Minneapolis and Oakland. The research team has developed a unique method to use retrospective and contemporary sources to create data on the timing and placement of introductions, renovations, and closures of: 1) food resources (e.g., restaurants, food shopping); 2) recreation facilities (e.g., trails, parks); and 3) transportation infrastructure (e.g., light rail, bike parking, bike paths) in Birmingham, Chicago, Minneapolis, and Oakland over a 25-year period. Furthermore, we have developed sophisticated statistical models that account for purposeful (as opposed to random) placement of relevant resources in the social environment as well as individuals' ability to selectively migrate to locate near such resources. Study objectives include: 1) Develop and validate new fine-grain measures to capture introductions, renovations, and closures representing changes in: a) parks, trails, and other recreational sites; b) food environments; and c) transportation infrastructure that will be contemporaneously linked to CARDIA respondents' geographic locations over 25 years; and 2) Using this unique data source, estimate the effects of introductions, renovations, and closures of key food and activity facilities and transportation infrastructure on diet and activity behaviors, body weight and cardiometabolic risk in the four field cities over 25 years, while accounting for the endogenous placement of food and activity facilities and selective migration. We will specifically focus on comparisons across individual-level race, income, and education groups to examine how environmental factors contribute to race and SES inequalities in diet, obesity, and cardiometabolic risk from young- to mid-adulthood. The proposed research will improve current understanding of the mechanisms through which social environments (specifically broader societal, economic, and environmental contexts) influence health outcomes.

Public health relevance
PROJECT NARRATIVE The US is experiencing substantial burden in obesity and cardiometabolic disease, yet very little research has addressed the specific factors and pathways linking the social environment to cardiometabolic risk. The objective of the proposed research is to improve understanding of mechanisms through which social environments influence obesity and cardiometabolic risk, determine which factors in the social environment are particularly influential, and to advance analytic methods to understand these complex pathways. Ultimately the proposed research will inform macro-level social environment policies to mitigate early development of disease risk in the early to middle adult years. __SpecificAimsTextDelimiter__ 2. SPECIFIC AIMS While observational research suggests an association between social environment factors with obesity and cardiometabolic risk factors,1-4 very little research has addressed the specific factors and pathways linking the social environment to cardiometabolic risk. In particular, owing to data limitations, there has not been adequate study of the influence of timing and placement of new food and recreation facilities and transportation infrastructure on diet and activity behaviors over time and the influence of these factors on obesity and cardiometabolic risk. One major concern is the minimal attention given to the assumption that such facilities and infrastructure are randomly or exogenously allocated across social and geographic space.5-8 In the proposed project, we will identify the multiple pathways through which environment influences changes in diet and activity behaviors, weight, and, further, the development of cardiometabolic risk, while taking into account purposive placement of facilities and infrastructure as well as the fact that individuals choose where they live. We use 25-year, longitudinal data from the Coronary Artery Risk Development in Young Adults (CARDIA) study, providing a wide age range, geographic diversity, and different patterns and pace of change across communities. We take advantage of existing, longitudinal neighborhood-level data that we have created with NIH funding (R01-CA109831; R01-CA121152) using Geographic Information Systems (GIS) technology (e.g., time-varying variables related to recreation, eating and food shopping facilities, crime, sociodemographics, and built environment factors) combined with newly proposed retrospective and contemporary data to create data on the timing and placement of introductions, renovations, and closures of: 1) food resources (e.g., restaurants, food shopping); 2) recreation facilities (e.g., trails, parks); and 3) transportation infrastructure (e.g., light rail, bike parking, bike paths) in the four CARDIA baseline cities: Birmingham, Chicago, Minneapolis, and Oakland over a 25-year period. We propose to estimate the effects of introductions, renovations, and closures of key food and activity facilities and transportation infrastructure on diet and activity behaviors, body weight and cardiometabolic risk in the four field cities over 25 years, while accounting for the endogenous placement of food and activity facilities according to demand and selective migration to take advantage of such resources. Aim 1: Using a method we have piloted (NIH institutional pilot grant P30 AG024376) in one of the field cities (Chicago), we will develop and validate new fine-grain measures to capture introductions, renovations, and closures representing changes in: 1) food resources; 2) recreation facilities; and 3) transportation infrastructure that will be contemporaneously linked to CARDIA respondents' geographic locations in the remaining three baseline field sites (Birmingham, Minneapolis, and Oakland) over the 25-year period at the appropriate Exam Years. These new data will be added to the CARDIA dataset for public use. Aim 2: Using the data generated in Aim 1, develop a model system to investigate how the timing and placement of changes in food resources, recreation facilities, and transportation infrastructure influence: a) individual-level dietary intake and physical activity, b) patterns of weight maintenance and gain, and c) incidence, persistence, and reversal of cardiometabolic risk factors over 25 years, controlling for the purposive placement of food resources, recreation facilities, and transportation infrastructure and for the selective migration of individuals to locate near such resources. We will specifically focus on comparisons across individual-level race, income, and education to examine how environmental factors contribute to race and SES inequalities in diet, obesity, and cardiometabolic risk. We hypothesize reduced frequency of fast food consumption with removal of fast food restaurants, and increasing physical activity and higher diet quality with the introduction and/or renovation of grocery stores, recreation facilities, and transportation infrastructure, with stronger effects in low socioeconomic status individuals and low socioeconomic status neighborhoods, with impacts on weight maintenance or attenuated weight gain, and reduced cardiometabolic risk. Impact: We will use innovative strategies and take advantage of unique data on social, environmental and economic changes occurring in four major US cities over 25 years, coupled with high quality behavioral, anthropometry and biomarker data, to determine whether the intermediate structural characteristics of macro- level social environments serve as conduits to affect health outcomes. We will use sophisticated statistical models that account for purposeful placement of relevant resources in the social environment as well as individuals' ability to selectively migrate to locate near such resources. Our pathway-based analyses address each piece of the complex system to investigate mechanisms underlying the links between social environment, behavior, weight and cardiometabolic risk. We focus on the transition from young- to mid-adulthood - the lifecycle period with greatest risk for development of cardiometabolic disease. Our project will make several important methodological contributions in terms of social environment measurement methods and analytic methods to account for endogenous placement of food and activity facilities and selective migration.